HOW WELL DO PHYSICIANS COMMUNICATE TEST RESULTS TO PATIENTS?

This study will try to ascertain how internal medicine faculty and resident physicians at the University of New Mexico Health Sciences Center currently notify their patients about test results; and to ascertain the expectations and preferences of patients regarding the test result notification process, and to see if different subsets of patients have different expectations and preference.